Creating an sxRNA Organoid Product for Advancing the Study, Prevention and Treatment of Alzheimer's disease (AD) and Alzheimer's-disease-related dementias (ADRD)

Abstract –
sxRNA Technologies (sxRNATech) is developing an organoid toolkit for Alzheimer’s Disease (AD) and
Alzheimer's-Disease-Related Dementias (ADRD) that will enable the identification of senescent cells in living
tissue providing a novel tool for studying senescence and how it relates to the aging processes while also
creating a new platform for high-throughput drug screening in in complex 3D tissue models. Complex 3D tissue
cultures such as ribbons, gastruloids and organoids, which utilize stem cells to re-create organs in vitro, have
tremendous potential for commercial and academic research. However, there are still limitations inhibiting their
widespread use for AD/ADRD research and drug development, especially with respect to senescent cells. The
harmful effects of senescence are attributed to high secretory activity, referred to as the Senescence Associated
Secretory Phenotype (SASP), which leads to fibrosis and decline in organ function. Although it is presently
unclear whether cellular senescence is a cause or a consequence of neurodegeneration and which comes first,
there is little doubt that the two are connected and a better understanding of the role senescence in AD and
ADRD is critical. sxRNA Tech is the pioneer of structurally interacting RNA (sxRNA), which is an RNA-based
technology that enables the specific mapping and manipulation of gene expression in living cells. sxRNA is
based on the binding of one RNA molecule to a second RNA molecule in a manner designed to “switch” the
structural confirmation of the first RNA into an active “functional” form. The presence of a selected cellular
microRNAs is then used to turn ON the translational activity of an sxRNA engineered mRNA by interacting with
it in a manner that creates a new binding site for a protein that regulates translation. The objective of this STTR
is to adapt the sxRNA technology, which is well established in traditional plated cell culture, to function as a tool
for screening of AD/ADRD drug candidates that limit senescence engagement in complex 3D human-cell
cultures that more close recapitulate human physiology and pathophysiology. During this (PhI) STTR project,
sxRNA Tech will expand the utility of the sxRNA platform technology for delivery, mapping, and control of
senescence in complex 3D tissue models. We will begin by developing an appropriate delivery vehicle for
introducing positive control sxRNAs into neural ribbons. We will then use this method to deliver reporter based,
switchable SENsxRNAs into ribbons demonstrating expression is restricted to senescent cells, and lastly, use a
therapeutic SENsxRNA to selectively eliminate and/or modulate cells from the 3D tissues. This will pave the way
for sxRNA Tech commercialization of products that enhance 3D tissue model expansion while increasing
standardization, providing new value to customers.

Public health relevance
Narrative – Alzheimer’s disease (AD) drug development has been an unfruitful and uphill battle leading to extremely limited therapeutic options and expensive clinical trials which ultimately end in failure. One of the causes of inefficient pharmaceutical identification and development of AD drugs is a lack of suitable model systems for high- throughput screening of senolytics and other AD therapeutics. sxRNA Technologies (sxRNA Tech) is developing an 3D human cell culture toolkit for Alzheimer’s Disease (AD) and Alzheimer's-Disease-Related Dementias (ADRD) that has the potential to distinguish senescent cells in real-time to be used to enable the in vitro validation of senolytic drugs using human-cell-based, 3D-cultures, enabling a greater understanding of the aging processes, cell death, quiescence, and senescence as it relates to Alzheimer’s Disease (AD) and Alzheimer's- Disease-Related Dementias (ADRD).